Development of anti-LTBP4 as a biologic to treat Limb Girdle Muscular Dystrophy 2C

Project Summary
Muscular Dystrophies are often rare, genetic disorders that typically result in progressive loss of muscle
strength effecting the ability to stand, walk, and breathe. Sarcoglycanopathies are an inherited form of Limb
Girdle Muscular Dystrophy (LGMD) caused by the loss of a, b, d, or g sarcoglycan proteins, rendering the
muscle membrane highly susceptible to injury. LGMD 2C is a severe subtype of LGMD resulting from loss of g-
sarcoglycan, with onset generally in the first decade of life. LGMD 2C is also known as R5. LGMD 2C is
clinically similar to the more common Duchenne Muscular Dystrophy (DMD) caused by the loss of dystrophin.
This similarity arises from sarcoglycan and dystrophin together contributing to the essential membrane
stabilizing dystrophin-glycoprotein complex (DGC). Currently, there are limited therapies available to correct or
delay LGMD 2C disease progression. Using an unbiased genomewide screen in LGMD 2C mice, Latent TGF-
b Binding Protein 4 (LTBP4) was discovered as a genetic modifier of muscle disease specifically modulating
muscle membrane stability and fibrosis. LTBP4 localizes to the exterior of the myofiber and extracellular matrix
where it binds and sequesters all three forms of TGF-b. LTBP4’s hinge can be proteolytically cleaved
promoting release of latent TGF-b, which is then activated triggering the downstream fibrotic cascade. Excess
TGF-b activation is a pathological finding in many forms of muscular dystrophy, especially LGMDs and DMD,
and excess TGF-b is linked to fibrotic accumulation in muscle and impaired muscle regeneration. In mice, the
genetic protective form of LTBP4 is less susceptible to protease cleavage, correlating with decreased TGF-
b activity and delayed muscle disease progression. Importantly, a similar protective genetic effect of LTBP4
was shown to modify disease progression in humans with DMD, reducing TGF-b release, correlating with
longer ambulation and improved heart function in three independent DMD cohorts. Combined, these data
provided the rationale to develop antibodies that stabilize the LTBP4 hinge and limit latent TGF-b release as a
therapeutic to treat muscular dystrophy. We demonstrated in the mdx mouse model of DMD that anti-LTBP4
antibodies directed at the hinge region are effective at mitigating disease progression. Anti-LTBP4 hinge
region antibodies protected against LTBP4 cleavage, reduced fibrosis formation, enhanced muscle
performance, and improved recovery after muscle injury. This proposal outlines a preclinical plan for testing a
2nd generation antibody for the treatment of LGMD 2C. This lead candidate has already been affinity and
sequence optimized. The milestones are designed to evaluate the PK PD relationship of this lead anti-LTBP4
antibody and assess in vivo efficacy in a validated mouse model of LGMD 2C. Completion of this award will
position the program to secure external funding from strategic investors and partners, which will aid in
advancing the anti-LTBP4 biologic therapy into the clinic.

Public health relevance
Project Narrative Limb girdle muscular dystrophy Type 2C (LGMD 2C) is a rare, progressive muscle wasting disorder that causes extreme muscle weakness and early morbidity. We identified a protective genetic effect of LTBP4 that improved muscle function in mice and humans with muscular dystrophy and subsequently developed an anti-LTBP4 biologic that elicited the same beneficial effects in a mouse model of Duchenne muscular dystrophy. We now propose to evaluate the therapeutic benefit of anti-LTBP4 antibody therapy in a preclinical mouse model of LGMD 2C.